EFFECTS OF CRANIAL, CRANIOSPINAL RT ON HPA AND HP GONDAL AXIS

The purpose of this project is to evaluate both the early and late effects of various doses of radiation therapy on the Hypothalamic- Pituitary-Adrenal (HPA) axis; to document the effect of high dose RT on hypothalamic-pituitary-adrenal function with regard to the timing and tempo of puberty; and to determine in a subpopulation of children exposed to high dose cranial irradiation, if suppression of the progress of normal puberty with the use of GnRH agonist therapy will improve the final height attained.